Interdisciplinary Training in Cardiovascular Research

ABSTRACT
This application is a competitive renewal of our (year 45) Cardiovascular and Pulmonary Research (CVP)
Training Program. The University of Arizona (UA) is a top 20 of Research I (R1) institutions and has a proven
track record of mentoring, research and collaborations across departmental and institutional boundaries. The
UA is the only R1 University with Hispanic Serving Institution and American Indian & Alaska Native-Serving
(AIANSI) status with 20% of all graduate students from underrepresented populations (URPs). The UA has seen
an unprecedented focus on heart, vascular and pulmonary research – bringing new, well-funded faculty,
committed to mentorship, to this renewal application. Substantive improvements in infrastructure and new
opportunities enable our trainees to gain true translational experiences. Two UA Colleges of Medicine - one in
Tucson (UA-COM-T) and one in Phoenix (UA-COM-P) are committed to translational CVP research by building
state-of-the art infrastructure through intra-institutional partnerships among key Research Centers. The CVP
Program is organized into 3 strong, synergistic interdisciplinary research themes: 1) Molecular Basis of Cardiac
Function and Disease, 2) Signaling in Vascular and Pulmonary Disease, and 3) Cardiovascular and Pulmonary
Disease – Molecules to Treatments. This organization creates a robust pipeline of integrative basic and
physician-scientist teams engaged in foundational physiological CVP research, with modern and relevant
research proficiencies, with verbal and written communication, mentorship, collaborative and networking
competencies. The CVP Program has evolved to meet the increased need for a diverse workforce and demand
in health-related careers by delivering a contemporary didactic experience in physiological CVP research,
applied research skills, and career development. All CVP Trainees benefit from state-of-the-art Core facilities,
CVP disease-focused Research Centers, and unmatched Institutional resources to address the modern-era of
data-driven research, including the “All of Us” Program, CyVerse and the Data Science Institute. The training
plan aligns with the NIH mission of T32 translational research training where predoctoral, MD/PhD, clinical and
postdoctoral trainees receive a broad background in biomedical and interdisciplinary research, multiple
experimental approaches, and practical and ethical aspects of careers in science. Trainees also develop
presentation and intrapersonal skills through journal clubs, MD/PhD colloquium, “meet the speaker” seminar
program and attending institutional, national and international Cardiology and Pulmonary conferences. The
postdoctoral training plan fosters a comprehensive path towards independence by expanding research focus,
learning state-of-the-art techniques, and honing scientific writing skills. Formal courses with active-learning
options are continuously revised (e.g., addition of courses on sex/gender differences and health disparities) and
global training in building translational teams via the Eureka International Institute is available. >90% of trainees
supported by this program remain in research-positions, a positive indicator of the success of our program.

Public health relevance
PROJECT NARRATIVE Heart, vascular and respiratory diseases continue to be leading causes of morbidity and mortality in the US, and reflect the complex interactions of environmental and genetic factors that modify the integrated function of proteins, cells, organs and organ systems and thereby, alter disease susceptibility, as well as responsiveness to therapies. Continued progress in precision diagnosis, treatment and prevention strategies for heart, vascular and respiratory diseases requires a mechanistic understanding at the systems level as it relates to the fundamental physiology of health and disease. Our long-standing translational cardiovascular and pulmonary (CVP) program, coupled with outstanding institutional support, provides trainees with opportunities to address modern-era data- driven research projects by delivering a contemporary and collaborative didactic research experience and professional development to train and mentor the next generation of CVP researchers.